Development of antigen multimers for CAR T cell detection and functional profiling

PROJECT SUMMARY
CAR T cell therapy offers new hope to patients with relapsed/refractory B cell malignancies and has become
another weapon in the war on cancer. Despite the success and excitement around CAR therapies, sensitive and
universal CAR-labeling reagents are required for accurate CAR T cell detection and profiling in research,
industry, and in the clinic. To improve CAR T cell therapy efficacy, scientists, clinicians, and the pharmaceutical
industry need accurate and multifunctional CAR-staining reagents to perform downstream assays, conduct
preclinical studies, profile patient biospecimens, and develop new CARs. To overcome this technology gap, we
developed antigen-multimers – high-avidity CAR detection reagents. Akin to conventional MHC multimers, our
preliminary data demonstrate that antigen-multimers sensitively and specifically detect CD19-directed CAR T
cells in commercial infusion products, in peripheral blood, and in tumor biopsies of diffuse large B cell lymphoma
patients. Furthermore, we show that CD19-multimers can be readily employed to isolate CAR T cells from patient
samples at different treatment stages for downstream flow cytometry and single-cell multi-omics analyses. In our
application, based on our exciting preliminary observations, we propose to test the overarching hypothesis that
antigen-multimers will enable CAR T cell detection and isolation and facilitate downstream single-cell analyses
of CAR T cells from patient biospecimens. Our antigen-multimers can be used to generate new knowledge
regarding CAR T cell function and in vivo efficacy.
In Specific Aim 1, we propose to develop antigen-multimers for high-sensitivity CAR T cell detection and
isolation. In addition to demonstrating the flexibility of our technology by generating 4 different CAR-detecting
antigen-multimers, we will also develop approaches for simultaneously isolating and restimulating CAR T cells
from patient samples in order to enable downstream phenotyping and functional analyses.
In Specific Aim 2, we propose to develop antigen-multimer-enabled single CAR T cell multicolor flow
cytometry and multi-omics. We will first use CD19-multimers to determine CAR expression, cell number,
differentiation, functional phenotype, and persistence of CAR T cells by multicolor flow cytometry. We will next
use CD19-multimers to isolate CAR T cells from responder and non-responder patients for subsequent single-
cell multi-omics analyses. Leveraging the experience of two investigators with complementary expertise in
immunoengineering (Huang) and translational/clinical CAR T cell therapy research (Kline), as well as the
UChicago Cell Therapy Biobank which contains hundreds of lymphoma and myeloma patient samples treated
with CD19- or BCMA-directed CAR T cell therapy, the proposed experiments will establish antigen-multimers as
a new class of CAR-staining reagents with broad research and clinical applications.

Public health relevance
PROJECT NARRATIVE CAR T cell therapy has revolutionized the treatment of relapsed/refractory B cell malignancies, but most people treated with CAR T cells don’t have durable responses, indicating that to improve CAR T cell therapy, we need better tools to measure how patients are responding. Existing tools to monitor a patient's cellular and molecular immune response to CAR T cell therapy are limited, so we developed antigen-multimer technology, which outperforms most available reagents in CAR T-cell labeling, and is useful in CAR T-cell detection, isolation, and downstream phenotypic and functional analyses. In this application, we propose to demonstrate the flexibility and broad applicability of antigen-multimer technology in labeling four different CARs, and by applying these reagents to analyze patient biospecimens using single-cell multicolor flow cytometry and multi-omics analyses.